AlloBrace: Pure Collagen Augment to Improve Performance and Integration of Allografts

Summary
An estimated 225,000 anterior cruciate ligament (ACL) tears are reported annually in the US, equating to
~$7B in medical costs. Tears of the ACL lead to instability of the knee and reduce mobility, if left untreated, it
can lead to chronic knee issues. Tears are typically treated by ACL reconstruction (ACLR) using either an
autograft or an allograft. Allografts only account for 22-44% of ACLR in the U.S. because autografts have a low
failure rate (5%). Harvesting an autograft causes donor-site morbidity (DSM) which leads to muscle weakness
of the ipsilateral leg, risk of infection, longer recovery time (9-12 months), chronic knee pain, and higher risk of
contralateral ACL tears. Use of allografts prevents DSM. Unfortunately, allografts have an ~14% failure rate and
are usually recommended for older and less active patients. Specifically, soft tissue allografts (STA) have poor
ligamentization and fail to form a true boney junction between the bone-graft interface. There is a need to improve
the biological integration of STAs to increase graft biomechanics, which will lead to lower failure rates. Therefore,
CollaMedix Inc. has developed AlloBrace to increase the biological integration of the allograft by stimulating and
guiding ligamentization throughout the STA and inducing true bony growth at the bone-graft interface. CollaMedix
is in the business of developing medical grade biotextiles using high-strength pure-collagen type I threads
produced by its patented high-throughput electrochemical compaction process. The collagen molecules in the
thread are unidirectionally aligned within threads, mimicking the native topography of ligaments and tendons,
which we have found makes the implant regenerative. Extensive in vivo research has found that new host
collagen is templated parallel to these threads, resulting in an ordered tissue deposition. Collagen threads also
impart a tenoinductive effect on stem cells topographically. The crosslinking agent genipin, which is used to
stabilize threads, polarizes macrophages to the pro-regenerative phenotype. A hydroxyapatite (HA) coating can
be added to impregnant the threads to be osteoconductive. Therefore, we have braided spooled collagen thread
with industrial braiding machines and coated each end with HA to create AlloBrace, a pure collagen sheath with
tenoinductive and osteoinductive potential. AlloBrace is simply deployed by sliding over the allograft and
prepared with traditional ACLR techniques and equipment. To validate AlloBrace, CollaMedix aims to confirm
the feasibility of AlloBrace as an enhancement for STA used in ACLR using a porcine model. We hypothesize
that AlloBrace will 1) guide cellular infiltration and tissue production throughout the allograft, and 2) stimulate
bone growth at the bone-graft interface within the bone tunnels. Specific Aim 1. Refine AlloBrace design to
improve graft conformity and to ease surgical deployment. Fabricate AlloBrace with varying diameters (6,
8, 10mm) and layer amounts (2, 3, 4) and determine which configuration conforms best to the STA. Specific
Aim 2. Show AlloBrace improves allograft healing biology and knee biomechanics. Compare
AlloBrace+STA vs. STA in an 8-week ACLR porcine study. Study assessment will be done by quantitative
histology analyzing immune response, wound healing, and tissue integration within the graft and bone-graft
interface, as well as biomechanical knee laxity tests. Phase I data will be used to justify future Phase II work to
test AlloBrace’s load sharing capacity and compare our device to predicate devices in a larger and longer in vivo
study (6 & 9 months). AlloBrace is poised to reduce allograft failure rates which would increase potential use in
ACLR and prevent autograft DSM.

Public health relevance
Narrative Anterior cruciate ligament reconstructions (ACLR) with allografts only account for 22%-44% of U.S. procedures because allografts have a high failure rate (8%-25%), making them not recommended for children and athletes, which is due, in part, to poor ligamentization throughout the graft and weak bone-graft integration within the bone tunnels. To reduce the chance of allograft failure, CollaMedix Inc. has developed AlloBrace, a pure collagen braided sheath with osteoinductive coated ends, that will induce new tissue growth throughout the allograft and promote true bony junctions between the bone-graft which will improve biomechanical allograft properties and increase pull out strength of the allograft, leading to a more stable knee. The proposed project will determine the feasibility of AlloBrace as a purely biological enhancement for allograft to advance ACLR by testing the implants delivery around an anterior tibialis allograft and the devices tenoinductive and osteoinductive properties in a in vivo pilot study using a physiologically relevant ACLR animal model, previously used for testing orthobiologics medical devices.